Assessing the Needs and Perinatal Health Outcomes of Women and their Children while on Probation: A Diversity Supplement

This attachment is not required for the diversity supplement request.

Public health relevance
PROJECT NARRATIVE This study addresses the gap in research by adding a diverse population to the science; the perinatal health of women on probation in South Texas, which is predominately Hispanic. Further, enhancing our understanding of the context-specific issues, such as the sexual health and violence that women on probation may experience, can better inform culturally tailored interventions and programs. Comparing health outcomes and stakeholder perspectives from those within the probation system to the prison system can robustly enhance our understanding of differences, variations, and opportunities for implementation across sites (prison and probation).